Platelet Metabolic Stress Induces Thrombo-Inflammation to Drive Endothelial Dysfunction in PH

Pulmonary arterial hypertension (PAH) is characterized by increased mean pulmonary artery pressure, that leads
to vascular remodeling and right heart failure. While endothelial cell (EC) dysfunction drives vascular remodeling,
the events that instigate EC injury are unclear. Platelets circulate proximal to ECs and experimental platelet
depletion has been shown to attenuate pathogenesis in PAH models. However, the mechanisms responsible for
this effect remain elusive. Notably, platelets are highly metabolically active and mediate vascular inflammation,
but these functions have not been fully considered in PAH. We showed that platelets from PAH patients display
metabolic dysfunction with increased fatty acid oxidation (FAO) and mitochondrial oxidants (mtROS). Preliminary
data indicate this dysfunction is caused by upregulation of the mitochondrial GTPase and mitofusin-1 (MFN-1),
stimulating activation of the NLRP3-dependent inflammasome. Cleavage of caspase-1, an essential component
of the inflammasome, leads to secretion of interleukin-1β (IL-1 β), platelet degranulation, and surface expression
of p-selectin (collectively labeled thrombo-inflammation). New data demonstrate that these platelet-dependent
events trigger EC oxidant production (via NADPH oxidase-1; NOX1) and EC proliferation. Hypothesis: Platelet
MFN1-dependent mitochondrial dysfunction triggers inflammasome mediated thrombo-inflammation, which
leads to EC dysfunction in PAH. Aim 1: Determine how MFN1-dependent platelet mitochondrial
dysfunction triggers inflammasome activation. Using biochemical measures in PAH patients’ platelets, we
will link mitochondrial dysfunction to inflammasome activation. We will induce PAH in transgenic murine models
of platelet-specific MFN1 and caspase-1 silencing, supplemented with lipidomics and redox modulation, to
determine the mechanism by which FAO and mtROS triggers inflammasome activation. PAH will be induced in
a novel secretome mouse to define vasoactive molecules released by platelet degranulation in PAH. Aim 2:
Determine the mechanism(s) by which platelet-driven thrombo-inflammatory signaling causes EC
dysfunction in PAH. Using human/murine platelet-EC co-cultures, we will characterize platelet-driven EC NOX1
activation and proliferation. Using antagonists to signaling mediated by IL-1β and platelet granule factors
identified in Aim 1, we will determine the platelet-dependent signaling axis that causes EC dysfunction. The
contribution of p-selectin dependent platelet-neutrophil aggregates will also be tested. We will utilize EC-specific
NOX1 knockout mice to test the role of platelet-mediated NOX1 activation in PAH. Aim 3: Determine if VX-765,
which inhibits caspase-1 to block inflammasome activation, and attenuates PAH pathogenesis. We will
test the efficacy of VX-765 (in clinical trials for non-PAH pathologies) in rodent models of PAH. These studies
will uncover a novel intra-platelet to EC signaling axis that defines the role of platelets in PAH pathogenesis and
reveals potential therapeutic targets.

Public health relevance
Circulating platelets are implicated in the development and progression of pulmonary arterial hypertension (PAH), a deadly disease of the lung vasculature for which there is no cure; but how these cells contribute to the disease is unknown. In this study, we will determine how changes in metabolism inside the platelet cause the platelet to spark inflammation in the blood vessels of the lung, which leads to injury of the blood vessel wall and development of PAH. If successful, this project will define the long unknown role of platelets in PAH progression, which will potentially lead to the development of therapies that target the platelet to treat PAH.